Cellular Aging and Rejuvenation: A Comprehensive Picture from a Dynamic and Network Perspective - Administrative Supplement

PROJECT SUMMARY No Changes from the originally submitted Project Summary

Public health relevance
PROJECT NARRATIVE No Changes from the originally submitted Project Narrative